PP2A B' subunit regulates synaptic development and cognition - learning fromhuman mutations

PP2A B’ subunit regulates synaptic development and cognition — learning from human
mutations
Abstract
Intellectual disability (ID) is a severe neurological condition affecting up to 3% of the general
population. There is currently no pharmacological treatment for ID patients. Gene-association
studies in ID patients identified an increasing number of genes. However, a vast gap persists
between gene discovery and treatment due to our poor understanding of the molecular
mechanisms linking cognition and genes. Two ID-linked genes are PPP2R5C and PPP2R5D,
both encoding brain-enriched B56 regulatory subunits of the PP2A phosphatase complex.
However, it is unclear how the ID-linked mutations in PPP2R5C or PPP2R5D affect the B56
subunit action and subsequent cognitive function. Our studies on wrd, the sole fly orthologue of
both PPP2R5C and PPP2R5D, shed light on how these specific subunits of PP2A
phosphatases regulate synaptic development, neural-activity-driven synaptic structural
remodeling, learning and memory. We found that Wrd-PP2A mediates dephosphorylation
events crucial for structural plasticity at the nerve terminals. Loss of wrd function destabilizes
active zones at the larval glutamatergic neuromuscular junctions, diminishes light-induced
remodeling of active zones at the photoreceptor synapses, and impairs gustatory learning in the
adult stage. Transiently expressing Wrd protein in adulthood restores the gustatory learning
defect in the wrd null mutant flies. These findings together suggest an exciting potential for
boosting Wrd-PP2A activity (or inhibiting antagonizing kinases of Wrd-PP2A) as a treatment for
ID. In this grant, we propose to generate and study fly Wrd transgenes that mimic the ID-linked
mutations in human patients. Our study will establish a fly model to dissect the molecular
mechanisms underlying the root causes of B56-dependent cognitive dysfunctions, paving the
road for future therapeutic approaches in treating B56-linked and other forms of ID.

Public health relevance
PROJECT NARRATIVE Mutations in a brain-enriched dephosphorylation pathway were identified in patients with intellectual disabilities. We found that disruption of the same pathway in fruit fly shows an aberrant structure in the neuron-neuron connections and insufficient learning capacity. This proposal will use the fly genetic model to understand the dephosphorylation-linked disease mechanisms of intellectual and developmental disabilities.